Probing Respiration and Metabolism of a Periodontal Pathogen

Project Summary
Periodontitis is a highly prevalent disease affecting nearly half of all American adults, and if left untreated leads
to bone loss and tissue damage [1]. Multiple microbes are associated with this disease [2, 3] and through
chemically-mediated interactions form complex interspecies communities within the periodontal crevice. Due to
the complexity of these chemically-mediated interactions, periodontitis remains a difficult disease to treat. Efforts
using polymicrobial communities [4, 5] and animal models [5, 6] have explored possible chemical interactions
and have greatly advanced our understanding of the chemical interactions occurring during periodontitis. In the
Whiteley lab we use a two-species model system composed of Streptococci gordonii (Sg), a representative
Gram-positive streptococcal species capable of consuming sugars and producing acids such as L-lactate as well
as producing hydrogen peroxide (H2O2), and Aggregatibacter actinomycetemcommitans (Aa), a Gram-negative
oral pathogen associated with aggressive periodontitis. Previously, we have shown that when grown in co-
culture, Sg cross-feeds Aa its preferred carbon source, L-lactate, while additionally providing the social cue H2O2
thereby enhancing the fitness of Aa [7-9]. By being cross-fed L-lactate, the slow-growing Aa is able to better
compete within a polymicrobial environment. Furthermore, H2O2 serves as a cue by stimulating the production
of the complement factor ApiA that protects Aa from complement killing [4], and induces the production of the
protein Dispersin B that allows Aa to control its spatial localization [9]. In addition to these fitness benefits, we
also hypothesize based on previous data that Sg-produced H2O2 also serves as a direct source of O2 for Aa
through catalase mediated detoxification [8]. While L-lactate and H2O2 have been shown to provide important
metabolic cues for Aa, recent genomic work indicates that there are likely additional chemical interactions
occurring between these bacteria during co-infection [8, 10]. Our hypothesis is that Aa displays defined
responses to Sg that are critical to establishing precise spatially structured biofilms at the micron scale.
The first objective of the project is to test the hypothesis that Aa can use O2 derived from H2O2 detoxification as
evidenced by a shift in respiration when Aa is grown in co-culture with Sg, and how H2O2 impacts spatial
structure. In the second objective we will use mass spectrometry to develop a comprehensive understanding of
the chemical interactions occurring between Aa and Sg. The results from these studies will provide direct insight
into the processes underlying the additional benefits Aa receives through H2O2 detoxification. By identifying the
unknown chemical interactions between Aa and Sg, we can better understand the complex interspecies
interactions involved in periodontitis.

Public health relevance
Project Narrative Periodontitis is a multifaceted disease caused by the concerted action of several bacterial species and by host inflammation within the periodontal pocket. Aggregatibacter actinomycetemcomitans (Aa) is often found in aggressive periodontitis, and it has been shown that chemical cues, including H2O2 and L-lactate produced by the oral commensal Streptococcus gordonii (Sg), enhance fitness. This proposal aims to understand if H2O2 detoxification provides sufficient O2 leading to a shift in respiration observed by Aa, and to investigate unknown chemical interactions that occur between Aa and Sg.